Project 1

PROJECT SUMMARY
Squamous cell head and neck cancer (SCHNC) results in extensive physical disfigurement, and leads to ~40%
5-year mortality; thus its prevention is extremely important. Blacks and people with low socioeconomic status
(SES) have a high burden of SCHNC. We hypothesize that the oral microbiota contribute to the racial and
socioeconomic disparities in SCHNC. Oral bacteria and fungi can cause epithelial cell DNA damage by carcinogen
metabolism, and some of these somatic mutations may be critical for SCHNC carcinogenesis. Bacteria and fungi
may also promote carcinogenesis through immunogenic stimulus for innate immune system response via pattern
recognition receptors, leading to immune cell recruitment and an altered tumor immune microenvironment. Thus,
a microbial role in SCHNC development and the shaping of the tumor mutational and immune microenvironment
is of great potential importance in the pathogenesis of SCHNC. Our preliminary data show that Blacks and
individuals with low socioeconomic status exhibit lower overall oral microbiome diversity, particularly characterized
by lower abundance of bacteria Corynebacterium and Kingella; we had previously reported that low abundance of
these two bacteria is also associated with increased risk of SCHNC development. Our work further points to
involvement of oral bacteria in carcinogen metabolism, with potential impact on tumor mutational load and
immune infiltration. While this preliminary data supports our hypothesis, no studies have examined the
comprehensive relationship between the oral microbiome, tumor microenvironment, and SCHNC in racial and
socioeconomic minority populations.
Our overall goal is to generate important biologic insights about oral microbial factors that underlie racial and
socioeconomic disparities in SCHNC development. In this research, we expect to identify specific oral microbiota
contributing to these disparities and to identify the tumor microbiota that influences host tumor mutation burden
and the tumor immune microenvironment. This project will help to achieve SCHNC health equity by generating
novel information from diverse population groups about the role of the oral microbiome in SCHNC development and
pathogenesis. Knowledge gained may improve our ability to identify people at high risk of SCHNC, particularly in
underserved minority groups. The new information may further lead to novel prevention and therapeutics approaches
that exploit microbially-driven immune responses in SCHNC.

Public health relevance
PROJECT NARRATIVE There are significant racial and socioeconomic disparities in the incidence of squamous cell head and neck cancer (SCHNC). We will test the innovative hypothesis that the oral microbiota contribute biologically to the disparities in SCHNC. This project will help to achieve SCHNC health equity by generating novel information about the role of the oral microbiome in SCHNC development, which may lead to novel personalized prevention and intervention approaches, in underserved minority and low-SES populations.